Single-molecule Visualization and Mechanisms of DNA Recombination and Intersecting DNA Transactions

Project Description
The broad objective of this proposal is to understand the mechanism of homologous recombination and its
relationship to chromosome maintenance in both Bacteria and Eukarya. Our approach is to reconstitute
increasingly more complex reactions that recapitulate the steps of the homologous recombination process,
using purified proteins from Escherichia coli and from Saccharomyces cerevisiae, and to use sophisticated
biochemical and biophysical methods of analysis. In particular, we will use single-molecule visualization to
image key steps and intermediates of these complex biological processes. We have developed new
experimental strategies for studying protein-DNA interactions at the single-molecule level. We devised several
approaches wherein we can easily manipulate an individual DNA molecule and expose it to a variety of
different proteins, enzymes, and buffers. Using fluorescent detection, we can image individual proteins on DNA
or detect their action on individual DNA molecules, typically in real-time. We propose to continue to use these
approaches to study unresolved aspects of recombinational DNA repair and its interface with the important
biological processes of chromatin remodeling and DNA replication. We seek to continue to address unresolved
questions regarding the dynamic behavior of RecA/Rad51 nucleoprotein filaments and their regulation by
protein mediators and modulators; the mechanism by which RecA and Rad51 find DNA sequence homology;
the reconstitution increasingly more complex recombination processes using purified proteins; the mechanism
and function of DNA helicases and their partner proteins; and understanding the mechanism of DNA
transactions that intersect with recombination, namely, chromatin remodeling and DNA replication.

Public health relevance
Project Narrative The broad objective of this proposal is to understand the mechanism of homologous recombination and its intersection with DNA replication and chromosome structure. We will reconstitute increasingly more complex reactions that recapitulate the steps of the homologous recombination process, and we will use single- molecule visualization to image key steps and intermediates of these complex biological processes.